Dissect the molecular mechanism of a viral genome packaging motor by an integrated structural approach

Project Summary
Biomotors are protein machines that convert chemical energy to different kinds of mechanical motions essential
to cellular functions. The bacteriophage φ29 genome packaging motor is one of the most powerful biomotors
reported. It is responsible for packaging the viral genomic double-stranded DNA (dsDNA) into a preformed
protein shell (procapsid) using adenosine triphosphate (ATP) as an energy source. Co-PI Guo has focused on
addressing basic questions on the mechanisms of assembly and function of the φ29 motor for decades. Recently,
the Guo lab proposed a revolving mechanism for the φ29 motor in which DNA revolves rather than rotates during
packaging. His lab has also demonstrated the feasibility of engineering and adapting the motor channel for DNA
sensing and fingerprinting at the single-molecule level. These findings bring about immense potential of the
powerful φ29 motor, but to fully embrace it for future nanotechnological applications will inevitably require a more
detailed understanding of how the motor assembles and operates, much of which is only beginning to be
elucidated. Major controversies still exist regarding the stoichiometry and architecture of the functional motor
complex and the mechanisms by which DNA is translocated. The overarching goal of this proposal is to elucidate
the molecular mechanisms of the bacteriophage φ29 dsDNA packaging motor through identification and
characterization of the motor complex at a variety of functional states using state-of-the-art cryo-electron
microscopy (EM) and molecular dynamics (MD) simulation, and leverage the knowledge gleaned for the design
and fabrication of a biologically active ATP-driven procapsid-free nanomotor that provides unprecedented
functionality. We propose three specific aims to tackle these challenging problems by integrating advanced cryo-
EM (co-PI Mao) and computational (PI Cheng) approaches with well-established biochemical/molecular biology
protocols (co-PI Guo) to increase the chances of success and impact of the results. In Aim 1, we will combine
cryo-EM and our advanced computational image analysis techniques to identify and characterize a variety of
motor intermediates in situ. To achieve high resolutions, we will explore ways to control the dynamics of the
motor to obtain structurally more homogeneous specimens. In Aim 2, we will implement and utilize a pipeline of
MD simulations to map the various cryo-EM structures obtained in Aim 1 onto the free energy landscapes of the
motor complex, and connect them into molecular “movies” to elucidate at the atomic level how stepwise,
distributed conformational dynamics in the motor complex are coordinated to drive DNA translocation. Finally in
Aim 3, we will leverage the molecular insights into motor assembly and operation gleaned from Aims 1&2 to
construct a biologically active procapsid-free φ29 mimetic nanomotor by reconstituting it into a lipid bilayer
platform, which will open up enormous opportunities for a wide range of applications in nanotechnology and
nanomedicine.

Public health relevance
Project Narrative This proposal aims to elucidate the mechanisms of a viral DNA packaging motor by an integrated cryo-electron microscopy (cryo-EM) and computational approach and to leverage the gained knowledge to assemble a functional motor complex in a lipid membrane. The proposed research will provide a foundation for the design of antiviral drugs and for the fabrication of artificial nanomotors for diagnostics and drug delivery.